FDA LFFM- Continuation of human and animal food/feed programs at the CT Agricultural Experiment Station

PROJECT SUMMARY- OVERALL CT AES LFFM 2020
Project Summary- This proposal, entitled “FDA LFFM- Continuation of human and animal
food/feed programs at the CT Agricultural Experiment Station,” is being submitted in response to
FOA-PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trial Not Allowed.
Our proposal includes 7 different projects encompassing Food Defense, Human Food Product
Testing, Animal Food Product Testing, Chemistry Capability/Capacity Development, Sample
Collection, NFDSX and ORAPP Integration, and Method Development/Validation. Each Project
is described in its own Component within Assist, as well as Overall and Admin core Components.
The Connecticut Agricultural Experiment Station (CT AES) has a 145-year history of food safety
research, including 15 years as a member of the FDA Food Emergency Response Network (FERN)
Chemistry Cooperative Agreement Program (cCAP), and 8 years of funding under 4 different FDA
ISO food safety CAPs. CT AES participates a broad range of surveillance and monitoring
programs to ensure the safety of food in the state. The primary goal of the current LFFM Proposal
is to acquire the necessary funding to enhance the capacity and capabilities of CT human and
animal food testing laboratories in support of an integrated food safety system. Specifically, CT
AES will conduct sample testing in the area of chemistry and will engage in the development
special projects that would support and expand that testing. This project will strengthen and
improve FDA’s efforts to prevent foodborne illnesses and minimize foodborne exposures through
building a nationally integrated laboratory science system. The funding will equip CT with
additional resources that can be employed to build and increase sample throughput capacity within
their state
The CT AES has demonstrated the expertise, capability, and adaptability to fully meet the
objectives of this FOA through our successful participation in a number of FDA CAPs, including
several specifically targeting food and feed product testing. Receipt of this new award from FDA
will significantly enhance the ability of the CT AES specifically, and CT in general, to meet the
program goals laid out in the FOA, and as described by the President’s Food Safety Working
Group, the Partnership for Food Protection and the Food Safety Modernization Act.
1

Public health relevance
The Connecticut Agricultural Experiment Station 123 HUNTINGTON STREET, P.O. BOX 1106, NEW HAVEN, CONNECTICUT 06504 Putting Science to Work for Society Protecting Agriculture, Public Health, and the Environment Founded 1875 Project Narrative- This proposal, entitled “FDA LFFM- Continuation of human and animal food/feed programs at the CT Agricultural Experiment Station” includes 7 different projects encompassing Food Defense, Human Food Product Testing, Animal Food Product Testing, Chemistry Capability/Capacity Development, Sample Collection, NFDSX and ORAPP Integration, and Method Development/Validation. The CT AES has demonstrated the expertise, capability, and adaptability to fully meet the objectives of this FOA through our successful participation in a number of FDA CAPs. Receipt of this new award from FDA will significantly enhance the ability of the CT AES specifically, and CT in general, to meet the program goals laid out in the FOA, and as described by the President’s Food Safety Working Group, the Partnership for Food Protection and the Food Safety Modernization Act. Phone: (203) 974-8500 Fax: (203) 974-8502 Toll Free: 1-(877) 855-2237, [email] PORTAL.CT.GOV/CAES An Affirmative Action/Equal Opportunity Employer